GENETIC REGULATORY MECHANISMS IN ESCHERICHIA COLI AND ITS BACTERIOPHAGE

The cAMP receptor protein (CRP) in the presence of cAMP can modulate the transcription initiation of many operons of E. coli. The protein is inactive in the absence of cAMP; when cAMP is present, the cAMP binds to CRP, causing a conformational change to an active form. We are studying how cAMP causes the conformational change in an effort to determine how a transcriptional regulatory factor can itself be regulated and to determine how an allosteric change in a protein can be accomplished. We have isolated, using mutagen-induced as well as site-specific mutagenesis, several classes of mutations within the crp gene that encodes CRP: crp* mutations that allow CRP to function in the absence of cAMP, crp*-intragenic suppressor mutations that force a crp* mutant to require cAMP, and crp** mutations that have even more cAMP independence than crp* mutants. Our current model for how cAMP induces the allosteric change in CRP is that cAMP binding alters the relative orientation of specific amino acids that are involved in subunit- subunit alignment, domain-domain alignment, and positioning of the DNA-binding F alpha-helices. Based on the locations within the CRP molecule of the substituted amino acids that cause the change, we have identified regions of CRP that are involved in the cAMP-induced conformational change.